Planning & Evaluation Core

ABSTRACT
The Planning & Evaluation Core (P&E Core) of the Partnership for the Advancement of Cancer Research
between New Mexico State University (NMSU) and Fred Hutchinson Cancer Center (Fred Hutch) coordinates
critical functions necessary for the determination of the impact and effectiveness of Partnership activities in the
attainment of its goals and objectives. P&E Core Leads, Dr. Rachel Boren at NMSU and Dr. Julian Simon at
Fred Hutch have extensive expertise in program evaluation methodologies. Dr. Boren is Director of the
Southwest Outreach Academic Research (SOAR) Evaluation and Policy Center at New Mexico State
University and has been an evaluator for over 10 years. She has previously worked as an evaluator for the
Institute of Translational Health Sciences (ITHS) based at the University of Washington. Fred Hutch is affiliated
with the University of Washington and participates in the ITHS thus giving Dr. Boren a unique familiarity with
both institutions. Dr. Simon has served as Research Project and Core Lead as well currently serving as MPI for
the Partnership. His nearly 20-year involvement with the Partnership gives him a historical perspective on the
culture of the collaboration. The five Specific Aims of the P&E Core are to: 1. Provide assessment tools to
evaluate, track and report on progress in all aspects of the Partnership; 2. Release Requests for Applications
for new pilot and full Research Projects and conduct rigorous review of proposals; 3. Engage community
members and community action boards to evaluate impact of the Partnership on advancing regional cancer
health equity; 4. Convene IAC and PSC to review progress of Cores and Research Projects, and facilitate
communication between the advisory bodies, NCI and Core and Project Leads, and; 5. Evaluate the
implementation and impact of the Guiding Principles (described in detail in Overall). In order to accomplish
these Aims, the P&E Core will work with the MPIs (Drs. Graciela Unguez and Julian Simon) as well as
Research Project and Core Leads to develop appropriate evaluation instruments to inform on the effectiveness
of the Partnership’s activities. Quantitative and qualitative measure of outcomes will be collected and assessed
based on the metrics described in the Logic Model (see P&E Core). New Research Projects will be solicited,
evaluated, and implemented through the P&E Core. Current Research Projects and Cores will be evaluated
and if necessary revised in consultation with the Internal Advisory Committee, the Program Steering
Committee and NCI Program Staff. Rigorous review of the effectiveness of projects and activities will enable
progress to meeting the Partnership’s goal of advancing health equity in the communities served.